Prevention of SUDEP by milk whey: Role of CO2 chemoreception and serotonin

Abstract
Sudden unexpected death in epilepsy (SUDEP) is the most common cause of death in patients with refractory
epilepsy. Emerging data indicate that a substantial percentage of SUDEP is due to seizure-induced respiratory
arrest. There is a gap in knowledge about how seizures cause apnea, who is at highest risk and what can be
done to prevent it. We have found that postictal death is due to seizure-induced apnea in two genetic mouse
models of human SUDEP (Scn1aR1407X and Scn8aN1768D mice). Our data indicate that seizures activate
projections from the amygdala to the brainstem causing central apnea, and transient defects in CO2
homeostasis and serotonin (5-HT) neuron function. This is supported by data showing that 5-HT neurons,
which are central CO2/pH chemoreceptors that stimulate breathing, are inhibited during seizures. The central
hypothesis of the current proposal is that seizures impair CO2 chemoreception, in part by inhibiting 5-HT
neurons, which increases the risk of a seizure becoming fatal. We have also found that a diet supplemented
with milk whey causes a large reduction in the risk of SUDEP, and this may be due to an increase in 5-HT.
This proposal will use Scn1aR1407X and Scn8aN1768D mice to carry out the following specific aims. 1) Determine
the role of impaired CO2 chemoreception in fatal post-ictal apnea. Working hypothesis: Seizures inhibit CO2
chemoreception, which increases the risk of fatal apnea. Our preliminary data indicate that generalized
seizures cause a large post-ictal decrease in ventilation, a decrease in the hypercapnic ventilatory response
(HCVR), and a transient drop in body temperature. All three of these homeostatic brainstem functions are
controlled by serotonin neurons. We will use 24-hour monitoring of EEG, EMG, EKG, plethysmography, body
temperature and video in a mouse epilepsy monitoring unit (EMU) to study changes due to spontaneous
seizures. 2) We will define the contribution of 5-HT system dysfunction to postictal hypoventilation and apnea.
Working hypothesis: Impairment of the 5-HT system worsens ictal and post-ictal hypoventilation. A decrease in
brain 5-HT has been shown to decrease the HCVR. We will increase or decrease brain 5-HT in mice and
measure the frequency of spontaneous sudden death, and postictal changes in the HCVR. 3) Define the
mechanisms by which whey prevents SUDEP. Working hypothesis: SUDEP risk is reduced by whey via an
increase in brain 5-HT and/or CO2 chemoreception. We propose to examine whether whey is effective in
preventing seizure-induced death in Scn8aN1768D, Kcna1-null and DBA/1 mice. We will examine whether whey
prevents inhibition of the HCVR with seizures. We will examine which components have a protective effect on
survival, and whether they act through changes in 5-HT. The expected outcome is that CO2 chemoreception
will be established as central to the mechanisms of SUDEP and to how whey protects against it. The broader
impact is that whey may be a new and safe approach to prevent SUDEP that targets mechanisms underlying
postictal respiratory arrest.

Public health relevance
Project Narrative SUDEP is a major cause of death in patients with epilepsy, and in many cases is thought to be due to postictal respiratory depression. Preliminary data support our hypothesis that seizures impair breathing by disrupting function of brainstem serotonin neurons that act as central CO2 chemoreceptors, and that dietary supplementation with milk whey decreases sudden death in epileptic mice by preventing this dysfunction. This proposal seeks to investigate the role of serotonin and chemoreception in SUDEP, and in the protective effect of milk whey, potentially offering a new avenue for preventative treatment of this common co-morbidity of epilepsy.